Microbiology Animal Food Project Testing Track 3 Accelerated Sample Preparation for Microbial Pathogen Detection in Pet Food Samples

Placedholder-Per Solicitation summary not required in Admin Component

Public health relevance
Placedholder-Per Solicitation Narrative not to be completed